Core B - Specimen Database.

CORE B SUMMARY/ABSTRACT
The main objective of this Core is to provide expert pathology services, in coordination with prospective
processing, database tracking, storage, and optimal distribution of serial biospecimens from AML and
MDS patients to support Core C and all 4 of the GAML Projects. After enrollment of AML and MDS patients
by Core A (Clinical Database), bone marrow, peripheral blood leukocytes, serum/plasma, skin, and oral mucosa
biospecimens are processed and banked by Core B (Specimen Database). These specimens and their
derivatives will serve as the basis for genome and transcriptome analyses and immunological assays in Core C
(Sequencing and Analysis) and Projects 1-4. This Biobanking Core will maintain and expand its
comprehensive database that annotates each specimen with information related to histopathology, disease
status, date collected/processed/distributed, processing performed, parent/derived specimen linkage, quantity,
quality, and availability. All specimens are anonymously linked to the patient of origin through unique patient
identifier numbers. Pathology expertise provided by Core B ensures the diagnostic accuracy of patient
specimens, optimal selection of malignant and normal tissues, and maintenance of quality control (QC) and
quality assurance (QA) standards and procedures within a CAP-accredited laboratory environment.
Specific Aim/Core Service 1:
We will prospectively process, annotate, and store serial biospecimens and derivatives from all AML and
MDS patients enrolled on the GAML protocol. Procedures that are customized and validated for GAML
Projects will be used. Viably cryopreserved cells will be banked for single cell RNA-seq, culture expansion, flow
cytometry, and immunologic assays. We will isolate high quality DNA/RNA for genome, epigenome and
transcriptome studies.
Specific Aim/Core Service 2:
We will provide expert pathology review and database tracking to identify and distribute biospecimens
for GAML studies. Core B will use its biospecimen database to provide histopathology, disease status, quality,
quantity, and availability data in real-time to enable optimal utilization the GAML Projects and Core C.
Histopathology services and pathology review will ensure accurate diagnostic information, provide
macro/microdissection of archived tissues, and optimal specimen selection and assembly of pathological subsets
for GAML Projects.

Public health relevance
PROJECT NARRATIVE: Core B Specimen Database The goals of the Specimen Database Core (Core B) are fundamental to all Projects (1-4) of the Genomics of AML proposal. In addition to providing expert pathology services, Core B will prospectively process, store, track, and distribute serial AML and MDS biospecimens from GAML patients at key clinical points (diagnosis, progression, relapse), using GAML-customized procedures that conform to College of American Pathology (CAP) accreditation standards and NCI’s Best Practices. Through these services, Core B will achieve objectives that are crucial for the goals of this program project: a greater understanding of the molecular pathogenesis of MDS and AML as a means to improve risk assessment and identify novel therapeutic targets for these aggressive diseases.